Reducing Plasma Cholesterol and Atherosclerosis Using miR-30c Analog C2

TITLE: REDUCING PLASMA CHOLESTEROL AND ATHEROSCLEROSIS USING MICRORNA-30C ANALOG C2
ABSTRACT
Despite the many treatment advances that have emerged in the past 75 years, cardiovascular disease (CVD)
remains a major cause of global morbidity and mortality; nearly one in five individuals diagnosed with heart
disease die prematurely. High plasma cholesterol levels substantially contribute to this problem. Thus, the overall
goal of this proposal is to identify novel ways to reduce plasma cholesterol levels and the risk of developing
atherosclerotic CVD. Our earlier findings have revealed that hepatic expression of microRNA (miR)-30c reduces
plasma cholesterol and atherosclerosis in mice. Here, we provide preliminary evidence that administration of C2,
a novel synthetic miR-30c analog, reduces plasma cholesterol levels in mice with diet-induced
hypercholesterolemia and Ldl receptor knockout. Based on these findings, we will test the hypothesis that C2
reduces plasma cholesterol levels by limiting the production of hepatic lipoproteins without causing hepatic injury
or an inflammatory/immune response. In Aim 1, we will explain the molecular mechanisms underlying the
observed C2-mediated reduction in plasma cholesterol levels. First, we will test the hypothesis that C2 limits
hepatic lipoprotein production by inhibiting the expression of microsomal triglyceride transfer protein. We will
also test the hypothesis that C2, beyond decreasing lipoprotein production, reduces fatty acid synthesis and
enhances fatty acid degradation, thereby averting hepatic lipid accumulation. We hypothesize that C2 reduces
fatty acid synthesis by downregulating Elovl5 and Elovl6. In addition, we will evaluate the role of newly identified
genes in fatty acid degradation, whose expression is upregulated in C2 expressing livers. In Aim 2, we
hypothesize that C2, given its unique mode of action, will act additively with other lipid-lowering drugs in reducing
plasma cholesterol and atherosclerosis. We will determine whether C2 functions additively with statins and
ezetimibe in reducing plasma cholesterol and limiting atherosclerosis progression. Second, we will determine
whether administration of C2 plus apoC3 inhibitors that lower plasma lipids by enhancing lipoprotein lipase
activity additively reduces plasma cholesterol, by performing studies in apoC3 knockout mice. Third, we will test
whether C2 reduces lipid levels when co-administered with GLP-1 agonists, which moderately lower plasma
lipids but are excellent drugs for diabetes and obesity treatment. In Aim 3, we will test the hypothesis that C2
lowers plasma cholesterol levels in non-human primates maintained on a Western-style diet. We will determine
whether C2 decreases diet-induced hypercholesterolemia by reducing hepatic lipoprotein production in these
non-human primates. We anticipate that the combined results of these studies will provide convincing support
for future human clinical trials of C2 as a first-in-class miR-based therapeutic that reduces plasma cholesterol
levels without causing hepatic injury or inflammation.

Public health relevance
Although many useful therapies are currently available, cardiovascular disease remains a major cause of premature mortality worldwide. Because of its positive relationship with atherosclerotic cardiovascular disease pathogenesis, new and more effective efforts to reduce plasma cholesterol levels are global goals. Here, we propose to evaluate the efficacy of C2, a novel microRNA 30c analog, in reducing plasma cholesterol levels and preventing atherosclerosis development in experimental rodent and non-human primate models.